Developing methionyl tRNA synthetase inhibitors as therapeutics for Chagas disease

Project Summary
In this project, inhibitors of the enzyme methionyl-tRNA synthetase from the protozoan parasite Trypanosoma
cruzi will be optimized to develop new drug candidates for Chagas disease. The available treatments for
Chagas disease are highly toxic and not fully efficacious, especially for the chronic stage. They need to be
replaced with safer and more effective drugs to treat the millions of people, mainly in Latin America, afflicted by
Chagas disease. The proposed research is based on the strong preliminary data of methionyl-tRNA synthetase
inhibitors from multiple chemical scaffolds showing nanomolar potency against T. cruzi cells, low toxicity to
mammalian cells, oral availability, and potent activity in murine infection models. We have chosen two
chemical scaffolds for lead optimization. Pre-defined criteria will be used to advance compounds through a
rigorous screening cascade, and the results will continually be fed back into the iterative design and synthesis
process. The goal for this project is to identify one preclinical candidate and at least one backup compound
that are ready for comprehensive GLP preclinical pharmacology and toxicology studies for further
development.

Public health relevance
Relevance The proposed research will help develop new treatments for Chagas disease, a parasitic disease common in Latin America that also infects >300,000 individuals in the USA. The existing drugs are limited by poor efficacy and toxicity. New drugs are desperately needed to help prevent deaths from damage to the heart and intestinal system caused by the etiologic agent of Chagas disease (Trypanosoma cruzi).